OXYRADICALS, ADENOSINE, STRESS PROTEINS AND PRECONDITION

DESCRIPTION: (Adapted from abstract): Recent studies have shown that a brief exposure to ischemia renders the heart better able to tolerate a subsequent longer ischemic insult, a phenomenon called ischemic preconditioning. The first hypothesis of this proposal is that ischemic preconditioning is accompanied by enhanced and sustained gene expression of HSPs in the heart of rats and rabbits. In addition to HSP70, the applicants will explore the role of other stress proteins such as HSP27, 60, and 90. The second hypothesis is that quercitine, an inhibitor of the heat shock transcription factor, blocks preconditioning by blocking the synthesis of HSPs. The third hypothesis is that oxygen radicals directly trigger the preconditioning and that scavenging of radicals by antioxidants attenuates the protection derived from preconditioning and reduces the expression of HSPs. The fourth hypothesis is that activation of adenosine A1-receptors during preconditioning results in enhanced expression of HSPs. The applicants will examine the effects of adenosine agonists and antagonists on preconditioning and HSP synthesis in rats as well as rabbits. The fifth hypothesis is that synthesis of HSPs mediates the second window of protection which develops 24 hours after ischemic preconditioning. The applicants anticipate answering the following questions: (1) whether preconditioning induces the expression of HSP27, 60, and 90 in addition to HSP70; (2) whether HSPs are involved in preconditioning early or late; (3) whether oxygen radicals trigger the preconditioning by inducing HSP; and (4) whether adenosine receptor activation induces expression of HSPs resulting in preconditioning.